Multi-scale modeling of glioma for the prediction of treatment response, treatment monitoring and treatment allocation

Project Summary/Abstract
Novel molecular technologies such as single cell RNA seq and DNA methylation assays have now become
routine techniques for gathering data at the molecular level including for Alzheimer’s disease (AD). Yet, these
technologies are still expensive and require fresh tissue, which not feasible for large cohorts. Moreover,
processing tissues for single cell analysis can distort gene expression profiles as well as the representation of
different cell types. Computational deconvolution methods can infer proportions of cells from bulk tissue assays
that have been minimally processed, retaining important information. We have previously developed and applied
such methods in the context of cancer biology. Here we will bring them to the analysis of Alzheimer disease,
interrogating unaffected vs early vs late affected

Public health relevance
Narrative We propose a multi-scale framework for treatment allocation, treatment follow-up and treatment monitoring to provide precision medicine for brain tumor patients. We will develop algorithms integrating clinical, molecular and imaging data for therapeutic purposes. We will focus on the development of multi-scale biomarkers that are predictive of treatment response, suggest the use of novel drugs and help during treatment monitoring.